VETERINARY STUDENT RESEARCH TRAINING PROGRAM

DESCRIPTION (provided by applicant): The objective of this Professional Student Short-Term Research Training Application is to provide veterinary students who have completed their first or second year with the opportunity to explore research in comparative medicine as a potential career. Students will be engaged in hypothesis-driven discovery and problem-solving research in a high-quality laboratory setting for 12 weeks during the summer. Only the best researchers/mentors from the College of Veterinary Medicine (CVM) at MSU have been included as trainees in the proposed research-training program. Participating faculty have been grouped into five areas of research excellence: 1) toxicology, 2) food safety and emerging infectious diseases, 3) comparative molecular genetics, 4) neuroscience, and 5) mechanisms of non-infectious pulmonary disease. In addition, an orientation, weekly seminar series, and field trips have been designed to broaden the research experience, as well as to provide students with an understanding of current research issues. The program is designed to successfully recruit veterinary students from other U.S. colleges of veterinary medicine and to ensure that minority students have access to this research experience. All students participating in the program are required to present their research results at the annual CVM Phi Zeta Research Day.